Training Program in Cell and Molecular Biology

(NOTE THAT margins are .75 in for abstract—original abstract was .50 inch margins)
We propose a flexible interdisciplinary Training Program in Cell and Molecular Biology – the Cell and Molecular Biology Training Grant (CMBTG) – at the University of Pennsylvania (Penn). The CMBTG is a University-wide, interdepartmental and interschool program whose mission is to provide a multifaceted doctoral program to prepare students for research-focused and/or research-related careers in cell and molecular biology in academia, industry, or government. The goals of the CMBTG are (1) to provide Trainees with both in-depth and broad-based training in cell and molecular biology research and modern methodology, while at the same time matching the Trainees’ specific interests, and (2) endow students with an appreciation for life-long learning in which they can adapt to shifting research needs within the cell and molecular biology fields. These goals are achieved through general and specialized courses, literature survey courses, laboratory rotations, a qualifying examination, thesis research with oversight from an advising committee and annual IDP submission, training in responsible conduct of research and scientific rigor and reproducibility, and training grant-specific activities. Trainee-specific activities include: an annual oral presentation of ongoing thesis research; attending the annual Cell and Molecular Biology Graduate Group Retreat; attending the Annual Trainee Organized Invited Lectures and meeting with the speakers; participating in Alumni Day designed to expose Trainees to a broad range of PhD-dependent careers; Current and Former Trainee Lunch in which former Trainees present a talk on their thesis research; Senior student mentored preparation of individual fellowships; Interactions with Pennovation Works, a business incubator and laboratory that aligns and integrates researchers, innovators, and entrepreneurs for the commercialization of research discoveries; and other activities. Trainees also work on presentation skills, including elevator talks, and learn how to write, defend, and review grants productively. Students completing their first year of graduate studies are appointed for two years and are selected annually by the Executive Committee. Trainers come from multiple Departments within the Penn Schools of Medicine, Veterinary Medicine, and Arts and Science, and affiliated Children’s Hospital of Philadelphia and the Wistar Institute. Trainers have active research programs in cell and molecular biology and a strong commitment to graduate education. The CMBTG has formal mechanisms to monitor Trainees both during and after CMBTG support and to train Trainers in mentorship and monitor them. Direct management of the CMBTG is done by an Executive Committee that sets and reviews policy and selects Trainees. Based on the number of potential trainees, we request support for 10 predoctoral trainees/year for the next 5 years.

Public health relevance
PROJECT NARRATIVE The Cell and Molecular Biology Training Grant seeks to broadly train PhD students in cell and molecular biology to adapt to changing needs in the biomedical research work force. This Predoctoral Training Program includes education and research opportunities to investigate the molecular and cellular basis of fundamental biological processes that range from cell signaling and architecture to gene expression, employing a wide array of model systems and state of the art imaging, molecular/cellular assays, and high throughput technologies. Career development opportunities are also central to the training program.